Core A: Administrative and Scientific Development Core

PROJECT SUMMARY/ABSTRACT
The goal of the Center for Microbial Pathogenesis and Host Inflammatory Reponses (CMPHIR) is to establish
a self-sustaining Center of Biomedical Research Excellence capable of addressing existing and emerging
problems in infectious disease in a timely and clinically relevant fashion. At the heart of this effort is the assembly
of a group of scientists who have research interests consistent with this scientific theme. Establishing and
maintaining an independent scientific career is a challenging task, thus making it imperative that these
investigators be provided with a strong support structure capable of meeting their administrative and technical
needs. Addressing the administrative needs of its investigators is the sole focus of the CMPHIR Administrative
and Scientific Development Core (Core A). To achieve this, Core A will provide CMPHIR investigators with an
integrated and adaptive administrative infrastructure to help them effectively navigate the institutional
environment and promote their overall faculty development (Aim 1), foster continued growth of the CMPHIR by
administering a robust and pro-active Pilot Grant Program and targeted external recruitment focusing on
investigators with research interests complimentary to existing CMPHIR investigators (Aim 2), and foster the
development of collaborative and synergistic interactions among CMPHIR investigators and among CMPHIR
investigators and other scientists on the host campus (Aim 3). Core A will rely on a seasoned administrative
team that has been in place since the inception of the CMPHIR and the expert advice of an internal Steering
Committee (SC) and an External Advisory Committee (EAC). The administrative team will also work closely with
the directors of the Scientific/Technical Cores (Cores B, C, and D) to ensure effective utilization of Core resources
on behalf of CMPHIR investigators and other scientists at UAMS. Thus, just as it did in Phases I and II, Core A
will provide administrative support to ensure a seamless transition into Phase III and ultimately an equally
seamless transition into a self-sustaining Center of Biomedical Research Excellence focusing on important
problems in infectious disease.